Characterizing mechanisms and consequences of intergenic transcription in human cancers

Abstract
Interpreting the role of intergenic sequences in tumor development remains an active area of research
critical to understand the overall influence of germline and somatic mutations on disease progression. Recent
studies have shown transcription and translation at ostensibly non-coding regions in different cell types, and
our own analysis of published datasets across cancer cell lines and patient tumors have revealed extensive
intergenic transcription and translation, particularly at or near structural variants (SVs). Given that SVs often
fuse genic and intergenic regions together, they are a plausible cause for several intergenic transcription and
translation events, and identifying such links would help establish a significant downstream consequence of
genomic instability and indicate how intergenic regions could shape tumor biology.
In Aim 1, we will develop a machine learning method to estimate the causal effect of SV presence
within a locus upon local intergenic transcription and compute such estimates across large public databases of
tumor genomes and transcriptomes. This aim will seek to address two outstanding problems in linking somatic
mutations to gene expression: (a) non-linear relationships between mutational load and expression magnitude,
and (b) the relative rarity of SVs compared to smaller somatic variation that can complicate causal inference.
In Aim 2, we will explore the role of nonsense mediated decay (NMD) in shaping the observed
expression levels of intergenic and fusion transcripts, particularly if the fusion transcript involves at least one
intergenic partner. Building on past studies studying how mutant transcripts evade NMD, we will determine
whether such predictions can explain observed variation in expression of SV-linked or standalone intergenic
transcripts across samples. By exploring the role of NMD, we will provide new insights into how intergenic and
SV-generated transcripts persist within the tumor transcriptome.
Finally, in Aim 3, we will analyze the landscape of SV-linked and standalone intergenic transcripts from
published datasets in which patients are treated with PD-1 or CTLA-4 checkpoint inhibitors. We will determine
whether an increased burden of intergenic transcription is associated with elevated immune infiltration and
inflammatory pathway activation and whether SVs that generate intergenic transcripts are linked to improved
clinical benefit. We will also test whether expression levels of transcripts predicted to evade NMD are also
associated with increased immune responses upon checkpoint inhibition. By analyzing immunotherapy data,
we can establish whether SV-linked or standalone intergenic transcription serves as a useful correlate for
improved clinical responses.
In summary, this study will develop computational approaches to test hypotheses on how intergenic
transcripts are generated and maintained and whether they are useful for immunotherapy. This research will
contribute new insights into the causes and consequences of intergenic alterations in the tumor genome.

Public health relevance
Project Narrative The genomes of cancer cells contain thousands of mutations, requiring specialized methods to determine how these mutations alter gene expression and tumor state. We have found that many cancer cells general novel RNA sequences arising from genomic regions without any known genes, and we hypothesize that such events may arise as a result of large-scale genomic rearrangements and evade normal cellular mechanisms to suppress aberrant RNA. We will develop computational tools to identify which kinds of genomic alterations result in these novel RNA sequences, what features help these sequences persist in the tumor, and whether these sequences influence the response to immunotherapy.